A Randomized Clinical Trial to Evaluate Solutions for the Management of Virologic Failure for Individuals on TLD in Sub-Saharan Africa

PROJECT SUMMARY
Significance: Tenofovir, lamivudine, and dolutegravir (TLD) has become the predominant first-line
antiretroviral therapy (ART) regimen in sub-Saharan Africa (SSA). While virologic failure on TLD is relatively
rare currently, rates will inevitably increase over time, threatening epidemic control in the region. The optimal
management of virologic failure on TLD is currently unknown, and policies vary widely in SSA. Innovation: We
propose the first randomized clinical trial to determine the optimal management strategy for virologic failure on
TLD in SSA. The trial will evaluate a novel individualized care strategy, which seeks to address diverse patient-
level determinants of virologic failure, including adherence challenges, pill burden, patient preference, regimen
tolerability, and drug resistance. The individualized care strategy incorporates a point-of-care urine tenofovir
assay, as well as genotypic resistance tests, with a goal of salvaging once-daily regimens among individuals
with virologic failure on TLD. Investigators: Our expert team of clinical epidemiologists (Suzanne McCluskey),
implementation scientists and clinical trialists (Mark Siedner, Monica Gandhi), global partners (Winnie
Muyindike, Richard Lessells, Mahomed Yunus Moosa), biostatisticians (Susanne Hoeppner), and decision
scientists (Emily Hyle), led by an early-stage investigator (McCluskey), is uniquely positioned to provide policy-
guiding data in response to this question of great public health significance. Approach: We will leverage an
established pragmatic clinical trial infrastructure which recently completed an NIH R01-funded randomized trial
in Mbarara, Uganda and Durban, South Africa to complete the following Specific Aims: Aim 1) We will
conduct the RESOLVE trial, an open, parallel arm, randomized clinical trial in six public sector clinics to
determine the optimal strategy for management of virologic failure on first-line TLD in SSA. We will randomize
participants to one of the following strategies: a) Maintenance on TLD with switch to protease inhibitor (PI)-
based second-line ART if virologic failure persists past six months, similar to current guidelines in South Africa;
b) Individualized Care, with regimen choice based on results of genotypic resistance tests and urine tenofovir
assays; or c) Immediate Switch to PI-based second-line ART, similar to current guidelines in Uganda. The
primary outcome will be viral suppression (<50 copies/mL) at 48-weeks post-enrollment. Aim 2) We will
populate the Cost-Effectiveness of Preventing AIDS Complications-International model with the clinical trial
data from Aim 1 to project long-term clinical outcomes and cumulative lifetime costs. We will use simulation
modeling to examine the clinical impact, costs, and cost-effectiveness of strategies to improve viral
suppression after virologic failure on TLD. Impact: We will respond to this priority research gap with data to
guide global HIV policy by determining the most clinically effective and cost-effective strategy for management
of virologic failure on TLD. In doing so, this proposal directly responds to NIH HIV research priorities to improve
viral suppression and to ensure that optimal treatment responses are achieved.

Public health relevance
PROJECT NARRATIVE The optimal strategy for management of people who experience treatment failure on tenofovir, lamivudine, and dolutegravir (TLD), the preferred first-line antiretroviral therapy regimen for over 25 million people in sub- Saharan Africa, is unknown. In this project, we will respond to this critical knowledge gap by conducting a randomized clinical trial in Uganda and South Africa to determine the most effective management strategy for people with treatment failure on TLD and will leverage data from the clinical trial to conduct a modeling analysis, which will compare the cost-effectiveness of each approach. Our results will inform regional HIV guidelines by identifying the most clinically effective and cost-effective strategy for the management of treatment failure on TLD in sub-Saharan Africa.